Self-help Computer Services for Eating Disorders

DESCRIPTION: (provided by applicant): This application proposes research related to NIMH Division of Services and Intervention Research. The aim is to design and test the first prototype of an interactive self-help computer program for binge eating disorder. The prototype will be based on an integrative view of the etiology of binge eating disorder, and will combine elements of various empirically supported treatment approaches. Each user will receive a customized learning experience, resulting in customized feedback from the program. We will conduct the following evaluations of the module: (1) Expert Reviews of Content and Usability, (2) Stage One Usability Test (with eating disorder subjects), and (3) Stage Two Usability Test (with eating disorder subjects). Dependent measures and formal criteria for success are specified. PROPOSED COMMERCIAL APPLICATION: Potential commercial markets for eating disorders self-help technology include psychotherapy clients, mental health professionals, and health maintenance organizations.